Fear and anxiety circuit mechanisms in anterior hypothalamic nucleus

Project Summary/Abstract
Acute severe stress plays a pivotal role in shaping mental health, predisposing individuals to an array of
debilitating conditions, including post-traumatic stress disorder and anxiety disorders. These conditions are
difficult to treat and available pharmaceuticals are of limited efficacy. There is therefore a great need to
discover novel treatments. Understanding how the brain processes the valence (i.e., magnitude) of stressful
experiences is critical for identifying new biological points of intervention. This is because the valence of
stressful events strongly influences their lasting consequences on disease-related behavior. Here, we propose
to explore the contribution of the anterior hypothalamic nucleus (AHN) – a brain region that has previously
received little attention – to the perceived valence and lasting impacts of stressful experiences.

Public health relevance
Project Narrative Acute severe stress plays a pivotal role in shaping mental health, predisposing individuals to an array of debilitating conditions including post-traumatic stress disorder and anxiety disorders. Here, we investigate how the anterior hypothalamic nucleus (AHN) – a brain region that has previously received little attention – modulates the negative valence of severe stress.